Southwest Health Equity Research Collaborative (SHERC)

PROJECT SUMMARY
Aligning with the NIH Strategic Plan for Data Science, the research team at Northern Arizona University (NAU),
a funded Research Centers in Minority Institution, proposes to increase and sustainably support data science
capacity and infrastructure at the University level. Through the first seven years of the Southwest Health Equity
Research Collaborative [(SHERC),
NIH U54MD012388], a strong foundation for health-equity research,
contributing to NAU’s expected R1 designation in 2025, has been built. However, NAU and SHERC still lack a
focus on data science. SHERC has successfully supported faculty in the use of the All of Us dataset along with
the
Science and Technology Research Infrastructure for Discovery, Experimentation, and Sustainability
initiative. The Science Collaborative for Health Disparities and Artificial Intelligence Bias Reduction (ScHARe)
data platform has yet to be implemented at NAU. To further bolster the data science infrastructure at NAU, this
project aims to 1) increase the data science capacity of NAU, ultimately expanding the institutional workforce,
and 2) increase utilization of Big Data by health equity investigators through enhanced data science curricula,
mentored training, and educational opportunities. SHERC will meet these objectives by hiring a data scientist,
creating a Data Science Skills Workshop series that includes skills and knowledge needed to use the ScHARe
platform, and mentoring doctoral and undergraduate students using the All of Us dataset.

Public health relevance
PROJECT NARRATIVE This project will address two specific goals of the National Institutes of Health Data Science Strategic Plan, including the National Institute on Minority Health and Health Disparities initiatives regarding the use of the Science Collaborative for Health Disparities and Artificial Intelligence Bias Reduction data platform. We aim to 1) expand the institutional workforce by hiring a new data scientist and 2) broaden the utility of, access to, and sustainable structures to support specialized tools through the proposed Data Science Skills Workshop series, and by mentoring doctoral and undergraduate students in the All of Us dataset, ultimately increasing data science capacity at the University.